Deciphering Mechanisms by which Tumor Cells Collaborate to Mediate Metastasis

Virtually all breast cancer (BC) related deaths result from metastatic burden rather than the primary tumor. It has
long been thought that primary tumors are heterogeneous, with only some cells having the capacity to
metastasize. Our work suggests that this view is oversimplified, and that non-metastatic cells can become more
metastatic due to paracrine-mediated signaling from other cancer cells. Understanding this mechanism will
uncover new strategies to inhibit metastatic disease.
To understand crosstalk between cells of varying metastatic potential in heterogeneous tumors, we examined
whether metastatic cells expressing the EMT-inducing transcription factors (TFs), Twist1 and Snail1, can
promote metastatic properties in intrinsically non-metastatic cells. Our data show that, in a manner dependent
on a third EMT TF, Six1, the EMT TFs can non-cell autonomously enhance metastatic properties.
Mechanistically, we show that cells expressing Six1 mediate paracrine activation of GLI-mediated signaling in
intrinsically non-metastatic cells, leading to increased aggressiveness and metastasis of these cells. Importantly,
paracrine mediated activation of GLI can occur through non-canonical pathways independent of Hedgehog (Hh)
ligands and Smoothened (SMO)-mediated Hedgehog signaling.
Our strong data lead us to hypothesize that SMO inhibitors, which are in clinical trials, will fail in a large
percentage of BC patients. We hypothesize that targeting GLI directly will be effective in a broader range of
breast tumors (encompassing subtypes that show features of EMT), and that determining the molecular
mechanism of non-canonical paracrine GLI activation will lead to additional therapies that are effective in a broad
range of BCs. Further, we hypothesize that targeting the central mediator, Six1, using our novel small molecule
inhibitor, will be efficacious in the broadest range of BCs due to its cell and non-cell autonomous role in tumor
progression. To test these related hypotheses, we will first determine the paracrine mechanism by which
EMT/metastatic cells increase the aggressiveness of intrinsically non-metastatic cells, focusing on VEGF-C and
its downstream signaling as key mediators. We will then perform a large scale head-to-head comparison of
inhibitors of EMT/metastatic and non-metastatic cell crosstalk in breast patient derived xenograft (PDX) models
that encompass various breast cancer subtypes and are metastatic, to determine which inhibitors are efficacious
in a broader range of tumors, and to characterize the types of tumors that will respond to specific inhibitors.
Our work may provide a partial explanation for why SMO inhibitors have been ineffective as single agents in
tumors such as BCs. Further, by uncovering a new mechanism by which EMT promotes metastasis, and by
deciphering the molecular components of that mechanism, we may not only provide an explanation for the
controversy in the field, but may more importantly identify highly efficacious means to target the many BCs in
which a percentage of cells have undergone an EMT.

Public health relevance
PROJECT NARRATIVE While the Epithelial-To-Mesenchymal Transition (EMT) has long been recognized as a potential contributor to metastasis in breast and other cancers, how and whether it is required for metastasis has remained controversial. Our data suggest that promotion of metastasis by cells that have undergone EMT may be due to paracrine stimulation of neighboring cells that have not undergone an EMT. This project will define the mechanism by which paracrine mediated metastasis occurs, focusing on non-canonical activation of GLI transcription factors, and will determine whether a range of inhibitors that target downstream or non-canonical activators of GLI, or that target a central transcription factor, Six1, will inhibit tumor cell crosstalk and thus inhibit tumor progression and metastasis in heterogeneous tumors.